Engineering Natural Killer Cells to Target Acute Myeloid Leukemia with HLA-DR Loss

PROJECT SUMMARY/ABSTRACT
Engineering T cells and natural killer (NK) cells with chimeric antigen receptors (CAR) has emerged as a powerful
new therapeutic approach for cancer, particularly hematologic malignancies. However, most target antigens are
not cancer-specific but are also expressed by normal cells (albeit often at lower levels), leading to severe “on-
target, off-tumor” toxicity. There is thus a critical need to enhance the anti-cancer specificity of CAR immune
cells. While cancer-specific antigens are rarely available, human leukocyte antigens (HLA) are often lost or
downregulated in cancer cells, presumably a mechanism to escape immune surveillance. For example, complete
or partial loss of HLA-DR, a class II HLA molecule, has been documented in approximately 17% of acute myeloid
leukemia (AML) at diagnosis and up to 50% of relapsed cases after transplantation. Our project aims to develop
a novel CAR-NK cell that can specifically target AML with HLA-DR loss. Our central hypothesis is that dual CAR-
NK cells, which express an activating CAR (aCAR) against CD33 (an AML antigen) and an inhibitory CAR (iCAR)
against HLA-DR, will eradicate AML with HLA-DR loss but spare normal myeloid cells, which are HLA-DR
positive. In preliminary studies, we engineered NK-92MI cells (a human NK cell line) to express a CD28/CD3ξ-
based anti-CD33 aCAR and a PD-1-based anti-HLA-DR iCAR. We found the resulting dual CAR-NK cells could
preferentially recognize CD33+HLA-DRneg cells over CD33+HLA-DR+ cells. However, the aCAR/iCAR pair was
designed based on T-cell signaling, which may not be optimal in NK cells. Here, we propose to test our
hypothesis by pursuing two specific aims: 1) Develop, validate, and optimize a pair of anti-CD33 aCAR and anti-
HLA-DR iCAR in NK cells in vitro; 2) Examine the anti-AML potency and specificity of single and dual CAR-NK
cells in mouse models. The proposed research is innovative, in our opinion, because HLA-DR loss is an immune
escape mechanism frequently observed in AML and other hematologic malignancies, but it has not previously
been exploited to enhance cancer targeting by CAR-T or CAR-NK cells. The proposed research is significant
because its successful completion will lead to a novel prototype of CAR-NK cells that can specifically target AML
with HLA-DR loss, which accounts for a substantial proportion of AML patients at diagnosis and relapse. This
approach, if proven successful, can also be broadly used to improve the targeting specificity of CAR-T/NK cells
against other types of cancer.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor natural killer (CAR-NK) cells are being actively developed to treat acute myeloid leukemia (AML), the most common leukemia in adults. However, current CAR-NK cells can induce unwanted killing of normal myeloid cells because the target antigens are not cancer-specific. This project aims to enhance the anti-cancer specificity by additionally targeting HLA-DR loss, a cancer immune escape mechanism found in many AML patients.